FY23 Supplement for NRT BIQSFP

This is a supplement application for Biomarker, Imaging and Quality of Life Studies Funding Program
(BIQSFP) funding for the following SWOG Cancer Research studies: S1602

Public health relevance
This is a supplement application for Biomarker, Imaging and Quality of Life Studies Funding Program (BIQSFP) funding for the following SWOG Cancer Research studies: S1602